Cutaneous biomarkers of pediatric non-alcoholic fatty liver disease

PROJECT SUMMARY/ABSTRACT
The objective of this multicenter study is to develop and validate a novel, non-invasive biomarker for pediatric
NAFLD. The specific aims are to recruit a cohort of 80 youth (6-21 years of age) with NAFLD and 80 controls
with obesity and study their skin surface lipids using state of the art lipidomic analyses to: 1. Determine the
cutaneous lipids that differentiate youth with NAFLD from controls; 2. Investigate the skin lipidome that detects
the presence of advanced disease (non-alcoholic steatohepatitis [NASH], fibrosis) among those with NAFLD;
and, 3. Further support the use of skin surface lipids as a biomarker of NAFLD in children by studying its
repeatability and variability. Participants will undergo magnetic resonance imaging with proton density fat fraction
(MRI-PDFF) at baseline to determine the presence/absence of NAFLD. This methodology has been shown to
be accurate in determining the presence of hepatic steatosis. They will then have their cutaneous lipidome
sampled using tape stripping. The latter is a rapid (<5 min), painless procedure that samples the lipids of the
most superficial layer of the skin (from the stratum corneum and the lipids secreted by the sebaceous glands).
All patients with NAFLD will have had prior histologic confirmation of their disease, which will be re-reviewed and
scored by a single pathologist, with expertise in pediatric NAFLD, who will be masked to patient clinical and
demographic characteristics. Untargeted lipidomic analyses of the collected skin samples will be performed using
ultra high-performance liquid chromatography-quadrupole time of flight mass spectrometry to determine the skin
surface lipids that alone or in combination predict the presence of NAFLD. The performance of the cutaneous
lipidome in predicting the presence of NAFLD in youth with obesity will be compared against that of the currently
used screening test, namely serum alanine aminotransferase levels. Among those with NAFLD, the performance
of skin surface lipids in predicting the presence of NASH and fibrosis will be assessed. Lastly, a subset of patients
with NAFLD will have repeat skin sampling: a. on the same day from the opposite arm, to test the repeatability
of cutaneous lipidome, and b. 1 month later, to test the variability of the lipidome as a biomarker. Variables that
may affect the skin surface lipids, such as sex, age/pubertal status, change in diet, obesity severity and insulin
resistance status, will be assessed and controlled for in these analyses. A non-invasive biomarker for pediatric
NAFLD is urgently needed, due to the staggering prevalence of this disease and the fact that the currently
available invasive diagnostic modalities (liver biopsy) are not practical and hinder therapeutic discovery and
progression.

Public health relevance
PROJECT NARRATIVE Non-alcoholic fatty liver disease (NAFLD) is the most common liver disease in the world, affecting 8% of all children and 34% or more of those with obesity. This study will determine and validate the role of skin surface lipids, which can be collected using painless tape stripping, as novel, non-invasive biomarkers of disease presence and severity in youth with NAFLD. The results have the potential to revolutionize clinical practice and to enhance therapeutic discovery, which is currently limited by the need for invasive liver biopsies to accurately detect and stage disease severity.